SPECIFIC CLEAVAGE OF PEPTIDES AT GLUTAMINE RESIDUES

The determination of peptide sequences is important in the understanding of molecular basis of disease, evolutionary relationships among proteins, and the relationship between protein structure and function. The rate-limiting step in determining protein sequences is the specific cleavage of peptides and proteins into well-defined fragments. There are few chemical methods that accomplish this objective. A new method of cleaving peptides as glutamine (Gln) residues is proposed in this work. The essence of this method is the conversion of Gln residues into 2,4-diaminobutyric acid (DABA) residues using a new reagent, I,I'-bis(trifluoroacetoxy)iodobenzene. It is proposed that the resulting peptides can then be cleaved at DABA residues in one or more of three ways: direct nucleophilic cleavage, transpeptidation-Edman degradation, and glyoxal-promoted cleavage.